MEMBRANE LUNGS FOR LONG TERM RESPIRATORY, CARDIAC AND CARDIORESPIRATORY ASSIST

Pulmonary ventilation in acute respiratory failure (ARF) is commonly geared to the recruitment of diseased lung through PEEP, and through the use of high airway pressures. We have now developed a new method of pulmonary ventilation that permits tidal volumes as low as 1 - 2 ml/kg, at respiratory rates from normal, to at least 120/min (Intratracheal Pulmonary Ventilation - ITPV). We have applied ITPV in the treatment of ARF in a sheep animal model, with low tidal volumes and normal peak airway pressure, and at a high respiratory rates, with eventual recovery. We believe future ventilatory care likely will include ITPV, at volumes and pressures shown not to cause underlying acute disease processes. We have developed a line of ultra-thin walled, spring-wire reinforced endotracheal tubes that exhibit airflow resistance equal to, or lower, than that found in healthy man. The key feature is a wall thickness of about 0.175 mm, and a two-stage design, with a moderately larger diameter within the oropharynx. A distal section of the endotracheal tube approximates a triangular shape, following the internal anatomy of the voice box. Instead of conventional cuffs, a series of soft "gills" provide a "no pressure seal", potentially greatly reducing morbidity associated with prolonged endotracheal intubation.